BLR&D Research Career Scientist Award Application for Priyattam J. Shiromani, PhD

70 million Americans suffer from some sort of sleep disorder. Behavior, mood and
memory deteriorate with sleep loss and it gets worse with continuing sleep deprivation. Sleep
disturbance is a frequent and common complaint among our Veterans. Lack of sleep due to
hyperarousal is one symptom of PTSD, but it is not known why Veterans with PTSD cannot fall
asleep. My research focuses on identifying and mapping the brain neurons that induce sleep.
The overall impact of my research is that it will provide the first direct evidence linking specific
phenotypes of neurons and their circuits responsible for inducing sleep. This will make it
possible to induce sleep in conditions where the arousal drive is very strong, such as in the
insomnia of PTSD, or to maintain wakefulness when there is excessive sleepiness, such as in
patients with obstructive sleep apnea or atypical depression.
I employ deep-brain imaging, optogenetics and CLARITY to identify functional circuits in
the brain. The brain contains many different types of cells but with the new tools it is possible to
disassemble the brain to identify the culprit neurons responsible for complex behaviors, such as
sleep. With the miniscope, we have gathered the largest database of neurons in the brain
(~1000 neurons; 4 phenotypes; MCH, GABA, Lhx6 and dynorphin) that show activity linked
specifically to sleep. As proof, we mechanistically (optogenetics) activated only a few neurons in
one small area of the hypothalamus in one brain hemisphere and discovered that it shifted a
waking brain to sleep. Other investigators are demonstrating that behaviors such as speech,
movement, vision can be triggered by activating small circuits in the brain. My intent is to
restore normal sleep when the circuit is affected by disease or trauma.
Overall, these neuroscience methods and tools aid the collective research effort at
RHJVAMC. My experience guides the junior faculty towards independence.

Public health relevance
Sleep disturbance is a frequent and common complaint among our Veterans and within the general population. Veterans suffering from post-traumatic stress disorder (PTSD) and depression have severe sleep disorders. In PTSD, there is a marked hyperarousal that makes it difficult for patients to fall asleep. The cause of the insomnia in PTSD is not known because we do not have a clear understanding of the brain circuits that induce sleep. I am using new genetically engineered tools such as optogenetics, deep-brain imaging and CLARITY to identify the brain circuits responsible for specific behaviors, such as sleep. My laboratory is actively engaged in mapping neural circuits, and training a new generation of scientists in the use of cutting-edge neuroscience tools and methods.